FY23. CTN CLINICAL COORDINATING CENTER TASK ORDER 12. SEPTEMBER 15, 2023 TO SEPTEMBER 14, 2028.

This Contract is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction and to develop concrete strategies capable of providing rapid and durable solutions to the opioid crisis.